Molecular Pathways of Pain Generation in Osteoarthritis

Project Summary
Osteoarthritis (OA) is the most common form of arthritis, and a major source of chronic pain. No disease-
modifying OA drugs are available to patients, and current analgesic approaches fall short of patients’ needs.
Nerve growth factor (NGF) has emerged as a promising target for OA pain. Neutralizing antibodies that prevent
NGF from binding to its receptor, tropomyosin receptor kinase A (TrkA), have shown strong analgesic effects in
clinical trials for OA pain. However, up to 10% of patients treated with anti-NGF developed rapidly progressive
OA, necessitating joint replacement. The mechanism of this deleterious effect of NGF blockade on joint
integrity is unknown, exposing our ongoing lack of understanding the relationship between joint damage and
pain in OA. During the previous funding cycles, we have developed assays, reporter mice, and
neuroanatomical and biophysical techniques for monitoring neuronal activity in vivo to assess pain behaviors
and underlying neurobiological mechanisms in mouse models of OA. We have uncovered that joint damage in
OA is accompanied by extensive anatomical and functional neuronal plasticity of the nociceptive innervation of
the knee. We will build on this discovery to test the central hypothesis that the NGF-TrkA axis is essential for
the preservation of joint homeostasis in response to joint injury, through neuronal and non-neuronal
mechanisms. We will (Aim 1) Determine the spatial and temporal NGF-TrkA “interactome” in the joint. Using
reporter mice, single cell RNAseq of the dorsal root ganglia (DRG), RNAscope, and immunohistochemistry, we
will detail which cells in the knee and DRG express Ngf and Ntrk1 during progressive experimental OA, in
spatiotemporal relationship to neuronal plasticity and joint pathology. We will validate findings in human knee
tissues; (Aim 2) Determine the role of the NGF-TrkA axis in promoting neuronal growth in the OA joint, and
how this contributes to pain and joint integrity. We will assess if NGF causes neuroplasticity, by injecting it into
knees of NaV1.8 reporter mice and assess pain behaviors, joint innervation, and joint integrity (histology and
microCT), as well as functional effects on sensory neurons. Advillin-creERT2 mice will be used to delete Nrtrk1
from sensory neurons in adult mice subjected to DMM or PMX surgery; pain, neuroplasticity, and joint damage
will be assessed up to 16 weeks; (Aim 3) Explore the role of the NGF-TrkA axis in OA through non-neuronal
mechanisms. We will use Ngf-loxp and Ntrk1-loxp mice to conditionally delete Ngf or Ntrka from select non-
neuronal cells (myeloid cells, osteoblasts, or chondrocytes). Mice will be subjected to surgery, and OA
monitored up to week 8; (Aim 4) Assess the effect of anti-NGF Abs on the OA joint. The role of the NGF-TrkA
axis in the whole joint as an organ will be determined by using neutralizing anti-NGF antibodies, either
prophylactically (0-8 and 0-16 weeks) or therapeutically (8-16 weeks) after surgery. This approach will clarify
how the NGF-TrkA axis operates at the interface between pain and joint damage in OA. Our experiments will
also start to address if and how the pain-producing and homeostatic actions of this axis can be dissociated, in
order to identify new targets for OA pain.

Public health relevance
PROJECT NARRATIVE (relevance to health) Osteoarthritis (OA) is worldwide a major source of chronic pain, and current treatments are insufficient. In depth study of the relationship between pain and structural changes in joint tissues, including changes in joint innervation, will have a major impact on development of more efficacious and safe treatments for OA.